Understanding fibrin-mediated immunomodulation in wound healing

PROJECT SUMMARY

The incidence of acute and chronic wounds from surgery, traumatic injury, diabetes, and metabolic syndrome is
on the rise, affecting over three million people in the US alone and costing tens of billions of dollars a year.
Successful wound healing progresses through coagulation/inflammation, proliferation, and remodeling phases,
culminating in tissue regeneration and/or contraction and scarring. Macrophages are essential mediators of
progression through these stages, and responsive to external therapeutic modulation. Yet, the soluble and
mechanical factors mediating macrophage interactions with these materials and other wound effectors remain
largely unknown. I propose to use immunology and bioengineering approaches to improve our tools and work to
fill this unmet clinical need. Our previous work demonstrated that fibrin, a major component of the provisional
extracellular matrix, skews murine bone marrow derived macrophages (BMDM) towards an anti-­inflammatory
phenotype in vitro, suppressing the stereotyped cytokine response to potent inflammatory stimuli, including LPS.
Preliminary data from 5 mm full-­thickness skin wounds in mice showed anti-­inflammatory skew in the wound,
measured by Arginase, iNOS, and YAP expression in macrophages, and diminished myofibroblast marker alpha
smooth muscle actin (aSMA) with fibrin treatment, suggesting a role for macrophage-­myofibroblast interactions
in the wound. Additionally, both soft (1.2 kPa) and stiff (840kPa) gels have been shown to increase macrophage
secretion of inflammatory cytokines seen in the stereotyped foreign body response (e.g. TNFa), with intermediate
stiffness showing lower secretion, indicating a mechanical sweet spot for immunomodulation. I propose to
engineer fibrin-­PEG hydrogels, mechanically optimized for macrophage immunomodulatory capacity, and apply
them to in vitro cocultures to determine macrophage-­fibroblast-­fibrin interaction dynamics and test the hypothesis
that fibrin hydrogels of moderate stiffness (~140 kPa) will best promote anti-­inflammatory macrophage
phenotype, facilitating decreased myofibroblast contractility. I also aim to define the mechanisms by which fibrin
hydrogels modulate macrophage phenotype to achieve wound healing and regeneration in vivo, using a full
thickness skin wound model in wild type, and selective immune cell depletions models (macrophage-­ MAFIA,
clodrosome;; neutrophil-­ anti-­GR1, B-­cell-­anti-­CXCL13). I will use histology, flow cytometry, and RNA-­seq to test
the hypothesis that fibrin-­PEG hydrogels of moderate stiffness (~140 kPa) will accelerate wound resolution and
tissue regeneration by promoting anti-­inflammatory macrophage phenotype. Understanding the mediators of
fibrin-­enhanced wound healing will help us better understand physiologic wound repair, and will lay the
groundwork for rational design of novel therapeutics, and better wound care for patients.

Public health relevance
PROJECT NARRATIVE The clinical and economic burden of acute and chronic wounds is large and growing, affecting tens of millions in the US alone and costing 10s of billions of dollars a year. Understanding the immune mediators of fibrin- PEG enhanced wound healing and regeneration will help us better understand physiologic wound repair, and will lay the groundwork for rational design of novel therapeutics, and better wound care for patients. I propose to integrate immunology and bioengineering approaches to fill this unmet clinical need.